Tranthyretin's Regulatory Role in Beta-Amyloid Aggregation and Toxicity

DESCRIPTION (provided by applicant): Beta-amyloid (Aβ) is the primary protein component of Alzheimer's disease (AD) amyloid plaques, and there is substantial evidence to support the hypothesis that soluble Aβ aggregates are neurotoxic. Transgenic mice expressing the Swedish mutation of the human Aβ precursor protein (APPSw) produce high levels of Aβ and develop amyloid plaques, but surprisingly they do not suffer the extensive neuronal cell death characteristic of AD. Recent studies have uncovered a possible explanation: APPSw mice upregulate synthesis of transthyretin (TTR), a transport protein found in plasma and cerebrospinal fluid, and TTR appears to protect the mice from the neurotoxic effects of Aβ. The long-term goals of this project are to answer three questions that arise from this intriguing discovery: (1) how does TTR exert its protective activity? (2) why does this natural protective activity fail in AD? (3) can it be restored or replaced? In aim 1, the specific residues on TTR involved with binding to Aβ will be identified. From mass spectrometry analysis coupled with peptide array binding studies, residues on the G strand and near the EF helix of TTR were implicated. Further definition of the binding site will be obtained by screening for Aβ binding to peptide library derived from overlapping sequences of TTR, and by targeted alanine mutagenesis. Compounds that mimic the TTR binding sites will be synthesized and tested for Aβ binding as well as inhibition of in vitro toxicity. In aim 2, the effect of TTR and variants on ? aggregation will be characterized. Preliminary data show that TTR quaternary structure and stability, oxidation, and binding of natural ligands all influence the extent of Aβ binding to TTR. The greatest Aβ binding is observed at intermediate aggregation states. Put another way, TTR may be a natural scavenger for the most toxic Aβ aggregates. Aggregation of Aβ in the presence of TTR will be characterized by a combination of dynamic and static light scattering, and nanoparticle tracking. These complementary methods, which are particularly suited for examining soluble aggregates, will yield data on aggregate size, size distribution, number, morphology, and aggregation rate. Synthetic mimics, developed in aim 1, will also be characterized for their effect on Aβ aggregation. In aim 3, further validation of TTR's neuroprotective action will be sought. Astrocytes will be transfected to secrete TTR (wt and monomeric), and inhibition of Aβ toxicity will be tested in vitro with mixed cortical cultures, or y adding medium from secreting astrocytes to highly enriched cortical neurons. Transgenic mice that overexpress TTR in astrocytes on an APP/PS1 background will be generated, and pathological endpoints will be evaluated to ascertain the level of in vivo protection afforded by TTR. Finally, initial screening of promising TTR mimics from Aim 1 will be tested in a stereotactic injection assay. These studies, which integrate chemical, biophysical, and biological approaches, will provide a rational basis for developing novel pharmacological approaches to preventing AD by enhancement of TTR's natural defenses. PUBLIC HEALTH RELEVANCE: Alzheimer's disease has been linked to deposition of beta-amyloid plaques in the brain and subsequent death of neurons. Studies with transgenic mice suggest that a normal protein, transthyretin may provide some protection against the neuronal cell death caused by beta-amyloid. This investigation will provide a rational basis for elucidating why this protective action of TTR is lost and for developing novel pharmacological approaches to preventing Alzheimer's disease by restoration or replacement of the natural defenses provided by transthyretin.

Public health relevance
Alzheimer's disease has been linked to deposition of beta-amyloid plaques in the brain and subsequent death of neurons. Studies with transgenic mice suggest that a normal protein, transthyretin may provide some protection against the neuronal cell death caused by beta-amyloid. This investigation will provide a rational basis for elucidating why this protective action of TTR is lost and for developing novel pharmacological approaches to preventing Alzheimer's disease by restoration or replacement of the natural defenses provided by transthyretin.